LIPOPROTEIN METABOLISM IN CONTROL SUBJECTS

High density lipoprotein (HDL) can be separated into distinct particles based on apolipoprotein content. The present study compares the in vivo metabolism of the 125I or 131I-labeled apoE-containing HDL particles LpE, LpE:A-I, LpE:A-II and LpE:A-I:A-II in controls and subjects with abetalipoproteinemia lacking apoB, by: study 1) injection of apoE particles purified from normolipidemic plasma; study 2) injection of apoE particles lacking apoB into normolipidemic subjects; and study 3) injection of apoE particles purified from abetalipoproteinemic plasma into abetalipoproteinemic subjects. The fractional catabolic rates in study 1 were for LpE:A-I, LpE:A-II and LpE:A-I:A-II, 2.67+/-0.37 d-1, 2.28+/-0.39 d-1 and 1.73+/-0.33d-1, respectively (p<0.005 for LpE:A-I vs. LpE:A-I:A-II); in study 2 for LpE, LpE:A-I, LpE:A-II and LpE:A-I:A-II, 3.33+/-0.37d-1, 3.08+/-0.35-d, 2.58+/-0.60d-1 and 2.47+/-0.44d-1, respectively (p<0.001 for LpE vs. LpE:A-I:A-II, p<0.05 for LpE vs. LpE:A-II, p<0.02 for LpE:A-I vs. LpE:A-I:A-II); and in study 3, for LpE and LpE:A-I:A-II, 3.58+/-0.48d-1 and 2.77+/-0.29d-1, respectively. ApoE-containing HDL particles were catabolized rapidly, and at a similar rate in normolipidemic and abetalipoproteinemic subjects, suggesting that the rapid catabolism is not explained by VLDL-IDL-LDL metabolism. Thus, the results of this study show that apoE-containing HDL particles are catabolized much more rapidly than apoA-I-containing HDL, with LpE<LpE:A-I<LpE:A-II<<LpE:A-I:A-II<< LpA-I<LpA-I:A-II. The presence of apoE changes the metabolic pathways of the particles, possibly by exposing them to the action of lipolytic enzymes, and promoting their uptake by hepatic receptors recognizing apoE.